Research Training/Educaiton Core

PROJECT SUMMARY (See instructions): The Education and Training Core is designed to increase the number of researchers prepared to address health disparities in their research and improve the quality of the training provided to clinical and basic science researchers conducting research on groups that experience health disparities with special regard to HIV/AIDS and aging. To achieve this overarching goal, the Education and Training Core will design, implement, and evaluate training at the undergraduate, graduate, post-doctoral (early career) and advanced career levels focusing on health disparity research pertaining to HIV/AIDS and aging. This will include multiple aspects of education and training, ranging from instituting ongoing and special lectures, hiring and inclusion of undergraduate and graduate research assistants, nurturing and mentoring graduate students and post-doctoral fellows, and advanced training of senior researchers who may be less familiar with health disparities research issues. We will (1) institute and evaluate trans-disciplinary learning such that scholars at all levels share and learn their knowledge across disciplines and subdisciplines because health disparities research pertaining to HIV/AIDS and aging involves knowledge bases from medicine, psychology, neuropsychology, anthropology, sociology, and neuroscience that focus from their respective prospectuses on focal problems and questions; (2) institute Collaborative learning such that ethnic minority research participants and trainees train more senior scholars who may have less emic knowledge and less electronic social network knowledge training. Emic perspective focuses on the intrinsic cultural distinctions that are meaningful to the members of a given society. Such collaborative approaches are fundamental to effective team development that will address health disparities and involve communities; and (3) work toward program sustainability, such that we institute the above training into a platform that has university and community sustainability and sustained partnerships, as it is critical to create a pipeline of new and continued research on health disparities.

Public health relevance
The Education and Training Core is highly relevant to the goal of advancing health disparities research on HIV/AIDS and aging because HIV/AIDS disproportionately impacts low income, ethnic minority individuals, especially African American. Moreover, the trans-disciplinary nature of health disparities on HIV/AIDS and aging means that research centers are ideal sites for such training which cannot occur within disciplines.